Oxidative Cysteine Modification by Thiol Isomerases in Sickle Cell Disease

Project Summary/Abstract
Vaso-occlusive events represent a major clinical burden in sickle cell disease (SCD). Vaso-occlusive events
recur in patients despite current treatments, including the use of hydroxyurea to increase fetal hemoglobin and
crizanlizumab that targets P-selectin for cellular adhesion. Oxidative stress in SCD increases the risk for vaso-
occlusion and current anti-oxidative treatments, including L-glutamine, show efficacy in decreasing these events.
However, antioxidants do not ameliorate vaso-occlusive crises. New treatment strategies for vaso-occlusion in
sickle cell disease based on an improved understanding of the redox mechanisms are required. Thiol isomerases
belong to a class of oxidoreductases that are secreted from platelets and endothelial cells and are required for
thrombus formation. The archetypal thiol isomerase, protein disulfide isomerase (PDI), promotes
thromboinflammation in SCD, is sensitive to the redox environment, and can be targeted with flavonoids such
as isoquercetin. Our preliminary data that isoquercetin decreases cell-cell adhesion in SCD mice suggests that
PDI could be a potential target for vaso-occlusion. However, the mechanism by which PDI promotes vaso-
occlusion is unclear. This proposal will test the central hypothesis that thiol isomerases promote redox-sensitive
vaso-occlusion through cysteine electron transferring events in sickle cell disease. We will evaluate redox stress-
mediated vaso-occlusion in SCD in three integrated aims using cell and chemical biology approaches with
murine models of the disease. In Aim 1, we will mechanistically examine the capacity of PDI to sense the redox
environment in SCD to promote electron transfers in the form of cysteine disulfides. This aim will determine
whether reduced or oxidized PDI promotes platelet and neutrophil activation in SCD by catalyzing electron
withdrawal from their known redox targets. In Aim 2, we will transition our studies to evaluate the function of
electron withdrawal mechanisms catalyze by thiol isomerases using intravital microscopy to observe thrombosis,
hemostasis, and vaso-occlusion in SCD. We will also complement the studies by observing the function of thiol
isomerase-mediated electron withdrawal on leukocyte cell-cell adhesion events in vivo. Lastly, Aim 3 will utilize
carbon nucleophilic probes that tag specific cysteine sulfur oxoforms to probe the global function of electron
transferring events in SCD. The probes will identify new targets of thiol isomerases in an unbiased manner in
order to determine whether a characteristic set of cysteine disulfide scission or formation is required for vaso -
occlusion. The probes will also identify mechanistically the role of cysteine electron transferring events on
hemoglobin function for red blood cell sickling and leukocyte-mediated cell-cell adhesion for vaso-occlusive
events. The K99 phase will focus on Aims 1 and 2 whereas the R00 phase will focus on Aim 3. The additional
training afforded by this career development award will not only enable me to expand my skillsets, but will also
uniquely position me to build an independent research program focused on oxidative cysteine modification in the
redox-regulated vaso-occlusive events of SCD.

Public health relevance
Project Narrative Vaso-occlusive events remain a clinical burden in sickle cell disease and is the major cause of organ failure. Although a major contributor to vaso-occlusion in this disease is redox stress, the mechanism by which redox stress promotes vaso-occlusion is not well understood. The goal of this project is to determine the role of oxidative cysteine electron transferring events in vaso-occlusion that are driven by thiol isomerases, which would reveal redox targetable mechanisms to prevent vaso-occlusion in sickle cell disease.